TgfB-dependent regulation of extracellular matrix-cardiomyocyte crosstalk

Project Summary
The extracellular matrix (ECM) is essential for maintaining cardiac structure and function. Aside from providing
structural support, the ECM relays molecular signals to cells via cellular attachment complexes and ECM-
sequestered growth factors to maintain cellular homeostasis. In response to acute injury or pathological stress,
excess ECM deposition occurs that can contribute to cardiac dysfunction. Transforming growth factor β (TGFβ)
is an ECM-sequestered growth factor that is released and activated by cardiac stress. Once released from the
ECM, TGFβ induces differentiation of quiescent fibroblasts into myofibroblasts which secrete ECM components.
However, the requirement for baseline TGFβ signaling in the heart remains unknown. Three TGFβ isoforms
exist encoded by three separate genes (Tgfb1, Tgfb2, and Tgfb3) although the specific roles of each TGFβ
isoform are not understood. To investigate the role of TGFβ ligands in regulating cardiac homeostasis, we
generated mice with cardiomyocyte (CM)-specific deletion of TGFβ ligands (Tgfb1/2/3fl/fl-αMHC-Cre). These mice
developed heart failure by 10 weeks of age accompanied by cardiac dilation without signs of fibrosis suggesting
defective ECM deposition. In contrast to previous studies demonstrating that TGFβ receptor deletion had
minimal effect on cardiac development, microarray analysis of Tgfb1/2/3fl/fl-αMHC-Cre hearts demonstrated a defect
in CM differentiation indicating a key role for the ECM in driving CM maturation. To circumvent a developmental
role of TGFβ, we employed a Tamoxifen-inducible CM-specific mouse model (Tgfb1/2/3fl/fl-αMHC-MCM) to delete
TGFβ ligands from the adult heart. These mice developed heart failure 12-16 weeks post-tamoxifen treatment
suggesting that TGFβ is required to maintain cardiac function in the adult heart. Surprisingly, fibroblast-specific
deletion of Tgfb1/2/3 did not develop cardiac dysfunction indicating that TGFβ is primarily generated by CMs.
Altogether, we hypothesize that TGFβ acts as a critical regulator of ECM-cell cross talk in the heart by signaling
to fibroblasts to promote ECM production, which ultimately provides signals back to CMs to maintain their
maturation. To address this hypothesis, we will use Tgfb1/2/3fl/fl-αMHC-MCM mice to determine the role of TGFβ in
maintaining CM differentiation. Specifically, we will assess these mice for cardiac function, CM maturation and
ECM composition and organization. Furthermore, we will perform RNA analysis at multiple timepoints both
before and after the onset of cardiac dysfunction to determine the transcriptional role of TGFβ in maintaining CM
maturation. Additionally, we aim to decipher the differential roles of each specific ligand (TGFβ 1, 2, or 3) in
regulating cardiac function. The proposed studies will further assess the role of TGFβ in mediating CM-cardiac
fibroblast crosstalk by studying fibroblast activity using in vitro models. Lastly, we will examine the composition,
organization, and mechanical properties of the ECM. Using mass spectrometry, we will identify potential ECM
structural proteins and growth factors that may have a role in maintaining CM maturation. Altogether, these
studies aim to understand the ECM-cellular crosstalk that occurs in the heart to regulate cardiac homeostasis.

Public health relevance
Project Narrative While changes in the extracellular matrix (ECM) are associated with heart disease, it remains unclear how components of the ECM provide crosstalk to cells of the heart to alter cellular function during cardiac remodeling. Using genetic mouse models, we have found that cardiomyocyte-specific deletion of the genes encoding TGFβ alters fibroblast function resulting in loss of ECM integrity and reduced cardiomyocyte maturation. The studies outlined here will decipher the requirement for TGFβ to maintain ECM integrity as well as cardiomyocyte maturation and fibroblast function in the adult heart and will further elucidate functional properties of the ECM that may regulate cardiomyocyte maturation.